SUPPORT FOR UNIVERSITY BIOMEDICAL EDUCATION

The main objective of the SUBE Program is to provide opportunities to investigator-professors and their student of the UPR, Rio Piedras for research and creativity in the biomedical sciences and their related areas. One aim is to permit young investigators begin to compete and possibly enter the mainstream of science. Those, as well as more established investigators will prepare graduate and undergraduate Puerto Rican students, many with social educational, and culturally limited backgrounds, to compete on a more equal level in science with students from more gifted institutions. This research program provides the students of the UPR, Rio Piedras, opportunities for research in the Departments of Biology, Chemistry, Microbiology, Pharmacology and Pharmacy, of the largest campus of the UPR system and its Medical School. In addition the Veterans Administration Hospital extends its collaboration to our students. The research proposal outlined here increases the communication and collaboration of the UPR system with its broad base of students with components of P.R. Medical Center focused around the UPR Medical Science Campus, thus, affording students and investigators a greater diversity of research activities in the biomedical field. In addition to the student benefits mentioned above, the Program allows for young, beginning faculty to get a good start in their research programs with funding from the SUBE Program. It also allows for established investigators the opportunity to pursue their research in a more vigorous manner at the same time offering the students the change to work with an established investigator. A further factor has been an increase in the curriculum in the various departments and collaboration among faculty.